Extended Longevity of 3D Tissues and Microphysiological Systems for Modeling of Acute and Chronic Exposures to Stressors

NIAID and the National Aeronautics and Space Administration (NASA), among other federal government entities, have partnered on a cofounded contract effort titled “Extended Longevity of 3D Tissues and Microphysiological Systems for Modeling of Acute and Chronic Exposures”. Money is provided by NIAID to NASA under an IAA, which is then used to award a contract to Dr. Wu at Stanford University) The agencies will oversee a 3D tissue chip project that involves adding a stressor of relevance to NIAID (radiation exposure) to demonstrate capability of the chip technology and explore the effects of radiation on the human cardiovascular system. This effort ultimately aims to create platforms of greater longevity which will have utility for understanding human pathologies on Earth and in space.